The ANKosome: a cytoplasmic activation platform for caspase-2

Project Summary
Caspase activation platforms (CAPs) are multi-oligomeric complexes essential for initiating cell
death or inflammation through the activation of initiator caspases. CAPs are pivotal players in these
processes; they are responsible for both sensing lethal/pathogenic stresses and, in turn, engaging
caspase activity in the cell. CAPs have come to define entire signaling pathways and include the
apoptosome (cyt-c/APAF1/caspase-9), DISCs (DR/FADD/caspase-8), inflammasomes
(NLR,AIM2/ASC/caspase-1) and the CAP for caspase-2 (C2), the PIDDosome (PIDD1/RAIDD/C2; the
main focus of our lab for the past decade).
Recent evidence points to the existence to at least one additional CAP for caspase-2 which, in
contrast to the DNA damage-sensing, nucleolar PIDDosome, assembles in the cytoplasm in response
to cytoskeletal injury. This RAIDD-dependent but PIDD1-independent C2 CAP may also be responsible
for C2 activation and ensuing neuronal cell death in response to beta-amyloid (Ab), as suggested by
elegant experiments in an in vitro model of Alzheimer’s disease (Carol Troy, Columbia University,
collaborator). However, the molecular identity of this novel C2 CAP distinct from the PIDDosome has
remained unknown. Through a genetic screen and additional preliminary data, we identify a strong
candidate for this complex, in which the cytoskeletal adaptor, ankyrin-G (ANKG), substitutes for PIDD1
as scaffold, thus physically coupling cytoskeletal integrity to C2. In ongoing experiments, the newly
discovered ANKG/RAIDD/C2 complex, which we designate ‘ANKosome’, assembles and drives cell
death in mammalian cells exposed to cytoskeleton-targeted anticancer drugs.
In this R21 application, the first to study the ANKosome, we will identify the precise ANKG
isoform which nucleates the complex and, through structure/function analyses, elucidate the
mechanism by which cytoskeletal injury triggers ANKosome assembly via ANKG. We will also delineate
the biologic function(s) of the ANKosome, with two main hypotheses. First, we will test whether the
complex truly transduces cytoskeletal damage into an apoptotic response in both mammalian cells and
live zebrafish embryos. Second, we will test whether the ANKosome mediates apoptosis in murine
neurons exposed to Ab using the Troy lab’s Alzheimer’s disease model discussed above. In further
support of this latter hypothesis, high levels of ANKG have been reported to accumulate at Ab plaques
in Alzheimer’s disease, contributing to the neurodegenerative phenotype.
This short term, high risk/reward project seeks to lay the foundations for a new field in apoptotic
signaling, that of the ANKosome, with potentially broad impact ranging from AD to cancer treatment,
that is, two of the major public health challenges facing our aging population.

Public health relevance
Project Narrative Coincident rises in the incidences of Alzheimer’s disease and cancer pose a major a public health challenge in our aging population. While research has implicated the cell death-inducing protein caspase-2 in both amyloid- b-induced neurotoxicity and tumor responsiveness to frontline cytoskeleton-targeting cancer chemotherapies, the underlying mechanisms have remained unclear. We will biochemically and functionally define a novel protein complex, the ‘ANKosome’, which we identify as a strong candidate for driving caspase-2 activation in both Alzheimer’s disease and cancer chemotherapy, thus potentially spurring drug development efforts with unusually broad relevance to seniors.